Hematologic Malignancies

The FASEB Scientific Research Conference on Hematologic Malignancies plays a key role in the professional and career development of the next generation of leaders in our field. Since its inception in 1995, this meeting has had a strong tradition of exceptional scientific programming, abundant opportunities for networking, and high-quality career development activities for our trainees. A critical feature of this meeting is the presentation of high-impact unpublished work in a setting that promotes discussion and sparks collaboration. The program reflects the full breadth of research in the field, spanning stem and progenitor dysregulation, premalignant hematopoiesis, molecular pathogenesis, immune and microenvironmental regulation, and therapeutics. The work of early career scientists is showcased throughout the meeting through lightning talks, poster sessions, and short talks selected from the abstracts. This meeting offers formal opportunities for mentorship through interactive panel discussions, meet the experts’ sessions, and numerous informal opportunities over shared meals and activities. The Aims of this proposal are to (1) develop a conference program that highlights the most innovative and impactful science in hematologic malignancies, (2) to catalyze scientific interactions and exchange of ideas during and between scientific sessions, and (3) to provide early career scientists with opportunities to present and discuss their research, network, and foster their career development. The sole budgetary request in this R13 application is for 50% support of the registration and housing costs for graduate students and postdoctoral fellows who will present oral or poster presentations at this conference. Funding of this application will ensure that early career scientists, who play a key role in its vibrancy, are able to attend.

Public health relevance
This meeting advances cutting-edge science and therapeutic development for patients with hematological malignancies. It is therefore directly related to blood cancers, a significant public health concern. CONFERENCE PLAN: 2025 FASEB Scientific Research Conference on Hematologic Malignancies OBJECTIVES: The overarching goal of the 2025 FASEB Scientific Research Conference on Hematologic Malignancies is to build upon the highly successful track record of this meeting as a catalyst for the scientific and career development of investigators in the field. The objective of this R13 application is to support this overarching goal by providing partial funding (50%) of the registration and housing costs for all trainees (graduate students and postdoctoral fellows) who will present oral or poster presentations at this meeting. Our goal is for NIH support to ensure that this outstanding conference (Figure 1) can continue to serve as a thriving intellectual environment that will catalyze the intellectual development of trainees into future leaders in the field. Held every other year since 1995, the FASEB SRC on Hematologic Malignancies has emerged as the premier scientific conference focused on the biology and therapeutic targeting of disorders of malignant hematopoietic development. The scientific program will focus on cutting-edge research, highlighting established investigators who are doing some of the most intellectually and technically innovative science in the field. Perhaps even more important is the exceptionally promising group of trainees and early-career investigators that this meeting attracts. The work of these scientists is featured prominently in the scientific program through talks selected from abstracts and poster sessions that foster lively Figure 1. Key components of the FASEB Hematologic Malignancies Conference 2025 discussions. The relatively isolated location of the meeting over five days ensures that most attendees spend the vast majority of their meals and free time together, maximizing opportunities for informal interaction between trainees and established investigators. We believe this meeting has been central to the unusual degree of cohesion and synergy within the field of hematologic malignancies, has contributed to key advances in our understanding of oncogenesis, and has aided the development of highly effective new therapies. The scientific program is designed to highlight the most innovative and exciting science in hematologic malignancies. The conference organizers draw on their experience with planning and attending national and international meetings and suggestions from colleagues to select the most exciting and innovative science to highlight at this meeting. Poster lightning rounds provide an opportunity for each scientist to introduce their work during the oral plenary session preceding each poster session. This drives attendance at the poster session and sparks interest from individuals across areas of research focus. This format contributes to poster sessions being the most interactive and stimulating part of the meeting. PROGRAM: The 2025 FASEB Scientific Research Conference on Hematologic Malignancies will be held July 27-31, 2025, at the Southbridge Hotel and Conference Center in Southbridge, MA. This retreat-like setting facilitates networking and informal conversation. However, it is still close enough to a major hub (Logan Airport, Boston) to help make travel economical for participants. Its key elements are: Opening keynote lecture: The opening keynote lecture will be given by Dr. George Vassiliou, Professor of Haematological Medicine at University of Cambridge, and Cancer Research UK Senior Fellow and Consultant Haematologist at Cambridge University Hospitals in Cambridge, United Kingdom. Dr. Vassilou is an internationally recognized leader in the field who has made seminal contributions to our understanding of clonal hematopoiesis and the acquisition of mutations across the lifespan. He is the recipient of numerous awards, including the UK National Clinical Impact Award and The Francis Hocking Prize in Medicine & Surgery from the London Hospital Medical College, and is a member of the Fellow of the Royal College of Pathologists. Closing keynote lecture: The closing keynote lecture will be given by Dr. Jennifer Trowbridge, Professor, Jackson Laboratory in Bar Harbor, ME. She is an internationally recognized expert in the hematology field and has made seminal contributions to our understanding of the role of aging and inflammation in leukemia evolution. She has received numerous awards, including the Scholar Award from the V Foundation for Cancer Research, the Leukemia & Lymphoma Society Scholar Award, and the Janet Rowley Award from the International Society for Experimental Hematology. Opportunities for students and postdocs to present: Trainees and newly independent investigators are the future of the field, and we strongly value their integration into all aspects of this meeting. Thirteen oral presentation slots are reserved for trainees or newly independent investigators to be selected from submitted abstracts. All poster presenters are also provided an opportunity to introduce their work via a short oral presentation as part of the Poster Lightning Rounds preceding each poster session. This approach increases the representation of young investigators, improves the quality of submitted abstracts, and helps organizers highlight the most cutting-edge late-breaking science. Career development programming: The formal career development activities in this meeting will consist of two interactive workshops and a Meet the Experts Lunchtime Roundtable Discussion. In addition to covering topics highly relevant for junior investigators, these workshops provide additional opportunities for scientists to interact with leaders in the field in a small group setting. In past years, this conference had one longer interactive workshop. In response to feedback from past trainees, for the 2025 meeting, we have chosen to have two shorter (1 hour long) workshops. This will allow trainees to attend the workshops and still have time for a break prior to the poster sessions and evening sessions. These workshops will focus on scientific and career development topics of particular interest to graduate students, postdoctoral fellows, and newly independent investigators. The career development activities will be announced several times during the meetings to build enthusiasm and drive attendance. Interactive Workshop 1: Building your CV as an Early Career Scientist This workshop will be formatted as a panel discussion with experts in the field. Four panelists will consist of a mix of engaged and supportive junior and senior faculty members. The target audience for this session is graduate students and new postdocs, but all will be welcome. Dr. Maxson will serve as the moderator and facilitate a lively and informal discussion between panelists and trainees. Although we plan for the trainees' questions to drive the panel discussion, we have outlined some potential discussion points: -Should I apply for a fellowship? If so, when? -How do I balance lab work with other activities? -How many papers should I strive to publish at a given career stage? -How do you tailor this approach for academic, industry, teaching, or other careers? -How to format an academic CV. Interactive Workshop 2: Moving to independence in academia or industry This workshop will feature a panel of 4 independent investigators, with at least one representative from industry. Dr. Doulatov will lead this informal discussion between panelists and trainees with a focus on how to prepare yourself to launch successful academic and industry careers. Although we plan for the trainees' queries to guide this conversation, some discussion points are outlined below: -Choosing a faculty or industry position -How do you build a successful team? -Fostering the development of your trainees/employees. -How do you develop leadership skills? -How do manage collaborations between your team and others? -Benefits of formal training in leadership or lab management The Meet the Experts Session will be geared toward career development and mentorship for graduate students, postdoctoral fellows, and newly independent investigators. This session will take place during lunch on Monday to encourage participation and give the opportunity for follow-up discussions throughout the week to facilitate further networking. Ten faculty mentors (selected from the speaker and sessions chair pool) will host five tables for interactive roundtable sessions. Trainees will be able to select topics that are timely and relevant for their career interests and stages. These will include: -Finding the right project and mentor. -Strategies for the academic job search. -Putting together a successful grant or fellowship application. -Finding an industry career. -Navigating publishing and peer review. Poster sessions: The poster sessions at this conference foster the liveliest and most scientifically exciting discussions during this meeting. Graduate students and postdoctoral fellows present most of the posters. Given our commitment to giving each poster presenter sufficient time to have in-depth conversations with multiple established investigators, we will hold three separate poster sessions. This limits the number of posters presented per session, which makes it possible for all attendees and established investigators to visit and have scientific discussions with all poster presenters in each session. The poster sessions keep the attendees fully engaged throughout the duration of the meeting. Table 1. Synopsis of Keynote and Plenary Sessions Opening Keynote Session George Vassilou (U. of Cambridge, England): Dynamics of premalignant expansion Plenary Session 1: Stem and Progenitor Dysregulation Dominique Bonnet (Francis Crick, London UK): Stem cell dynamics Eric Pietras (University of Colorado): Inflammatory regulation of stem cell biology Britta Will (Albert Einstein): Mechanisms of stem cell aging Sandrine Roulland (INSERM): Lymphoma clonal precursor cells Short talks selected from abstracts (3) Plenary Session 2: Molecular Pathogenesis I Ricardo Dalla-Favera (Columbia): Super enhancers in lymphoid biology Kira Gritsman (Albert Einstein): Oncogenic signaling in myeloid leukemia John Licht (University of Florida): Epigenetic dysregulation in multiple myeloma Omar Abel Wahab (MSKCC): Molecular mechanisms of lymphoid and myeloid malignancies Short talks selected form abstracts (1) Plenary Session 3: Pre-Malignant Hematopoiesis Lachelle Dawn Weeks (Harvard): Interventions Alex Bick (Vanderbilt): Comorbidities and clonal hematopoiesis Grant Challen (Washington University): Epigenetic dysregulation and premalignancy Eirini Papapetrou (Mt Sinai): Modeling premalignant hematopoiesis Short talks selected from abstracts (3) Plenary Session 4: Therapy for Heme Malignancies Alejandro Gutierrez (St. Jude): Novel therapies for hematologic malignancies Justin Taylor (University of Miami): BTK therapy resistance Ben Ebert (DFCI): Cereblon Degraders for heme malignancies Ash Alizadeh (Standford): Lymphoma genomics and therapy response Short talks selected from abstracts (1) Plenary Session 5: Immune System and Microenvironment Bethany Mundy Bosse (Ohio State U.): NK cell control of heme malignancies Marcela Maus (Mass Gen): Immunotherapy for lymphoid malignancies Markus Manz (Universitas Spital Zurich): CART therapy for hematologic malignancies Cristina Lo Celso (Imperial College London): Intravital imaging of the leukemia microenvironment Short talks selected from abstracts (2) Plenary Session 6: Emerging Technologies Dan Landau (NYU): Technologies Jason Buenrostro (Harvard): Application of new epigenetic technologies to the studyof hematopoiesis Diana Passaro (Institut Cochin): Engineering and imaging of the bone marrow Aaron Viny (Columbia): Perturbations of 3D chromatin architecture in leukemia Short talks selected from abstracts (1) Plenary Session 7: Molecular Pathogenesis II Esther Obeng (St Jude): Splicing dysregulation in myelodysplastic syndromes Teresa Palomero (Columbia): Mechanisms of T cell lymphomagenesis Ross Levine (MSKCC): Molecular mechanisms of myeloproliferative neoplasms Short talks selected from abstracts (2) Closing Keynote Lecture Jennifer Trowbridge (Jackson Laboratories): Aging and inflammation in the development of malignancy JUSTIFICATION FOR THE CONFERENCE The FASEB Hematologic Malignancies Conference occupies a unique niche. There is no other conference in the field that brings together so many of the leading established investigators and highly promising young scientists in a close-knit setting that promotes extensive scientific and professional interactions. A fully registered conference has <200 attendees (155 at the last in-person meeting in 2023), and nearly all are housed in the meeting facility. The retreat-like setting with shared housing and dining space ensures that all attendees spend most of their free time together. This format promotes highly productive scientific interactions and the development of long-lasting professional networks and collaborative relationships with mentors and peers in the field. To justify the need for this conference, the other meetings attended routinely by investigators in the field are shown here, together with a justification for the unique nature of the FASEB conference. American Society of Hematology (ASH) Annual Meeting (every December): This meeting draws many of the established investigators in the field. However, the sheer size of this meeting (>20,000 attendees versus <200 at the FASEB conference), as well as its location in a large urban area without shared meals or housing, makes it exceptionally difficult for trainees to meet and interact with established investigators that they do not already know. Junior trainees, in particular, have a tendency to feel a bit overwhelmed by this meeting, which has a large number of concurrent sessions. This meeting format is, in our opinion, ill-suited to support the career development of early-career scientists whose mentorship and scientific networkare still under development. American Association of Cancer Research (AACR) Annual Meeting (every April): Like the ASH annual meeting, this conference draws tens of thousands of attendees in a large city without shared meals or housing. This makes it extremely challenging for trainees to meet with and interact with faculty and trainees doing relevant work. Additionally, the biology of hematologic malignancies has a comparatively small footprint at this meeting, where solid tumors predominate. AACR Special Conferences on Myeloid Leukemia (Last offered in 2023) and Pediatric Hematologic Malignancies (Last offered in 2023): These conferences focus only on a subset of the field of hematologic malignancies and lack the exposure to the cutting-edge research across the breadth of research in multiple sub-fields within hematologic malignancies (namely lymphoid malignancies and adult hematologic malignancies respectively). It is not yet clear if these meetings will be offered again in 2025. Additionally, these meetings lack the critical mass of students and postdoctoral fellows in attendance that make the FASEB conference such a compelling experience for trainees who are building their professional networks. Gordon Research Conferences and Keystone Meetings. Although they are similar in format, no Gordon Research Conference or Keystone Meeting have significant overlap with the focus of this conference. The Keystone Hematopoiesis meeting (last held in early 2024) is the closest, but it largely focuses on normal as opposed to malignant hematopoiesis and is, therefore, conceptually and thematically distinct from this meeting. The FASEB Hematologic Malignancies Conference fosters scientific interactions and exchange of ideas to catalyze advances in the field. The intense scientific focus, intimate setting (<200 participants), and the collegial atmosphere foster extensive interactions and exchange of ideas throughout the duration of this four- day meeting. In addition to the robust question & answer sessions after each oral presentation and the lively discussions throughout the poster sessions, informal discussions over meals and during breaks are as important as the presentations themselves. While numerous scientific discussions emerge directly from the work presented, many others are spontaneous discussions that build upon shared interests among small groups of scientists. 2023, we had participation from editors from the Journal of Experimental Medicine and Blood Cancer Discovery. We will encourage attendance by scientific editors again in 2025 to enable participants to interact with the editors about upcoming manuscripts. The poster sessions are a particularly rich environment for scientific discussion and exchange of ideas. The “Poster Lightning Rounds” sessions provide an opportunity for each poster presenter to briefly introduce their work via a short oral presentation during the Plenary Session immediately preceding each poster session. This greatly facilitates stimulating and productive interactions at the poster sessions and is a lively and engaging part of the program. There are numerous examples of such discussions leading to high-impact changes in approaches and new scientific directions for the work presented. This type of exchange of ideas among a group of highly innovative and collegial investigators catalyzes advances in ways that are almost impossible to achieve by scientists working in isolation. Logistical Arrangements: Organizing Committee: The co-organizers of each FASEB hematologic malignancies conference are elected at the prior conference. The organizers of the FASEB hematologic malignancies conference are Dr. Julia Maxson, Associate Professor of Division of Oncological Sciences, Medicine, and Cell, Developmental and Cancer Biology at the Knight Cancer Institute School of Medicine of Oregon Health and Science University, and Dr. Sergei Doulatov, Associate Professor of Division of Hematology and Oncology, and Adjunct Professor of Genome Sciences at University of Washington. The co-organizers solicit feedback from prior meeting organizers, attendees, and leaders in the field when devising the schedule and selecting speakers for the conference. Basis for Selection of Key Participants: The major objective in selecting keynote speakers and oral presenters is to highlight the most innovative and exciting science in the field. This includes highlighting cutting-edge science across the multiple subfields of hematologic malignancies. Special attention is paid to research that leverages various experimental models and techniques. In response to feedback from past participants, we are making a concerted effort to have additional speakers in the areas of lymphoma, myeloma and other lymphoid leukemias. Resources for Family Care: Although child or family care is not provided by FASEB directly, larger hotel rooms and connecting rooms are available for attendees who may wish to bring additional guests to the meeting. FASEB offers discounted rates for guest attendees. FASEB also offers an alternative off-site registration fee, which covers the meeting and meals but allows attendees to book their own accommodations for those attendees who prefer to book their own housing. FASEB also provides information on the conference venue and area organizations that can assist attendees with locating licensed childcare providers. Anticipated Geographic Conference Area: This conference draws scientists from a broad national and international geographic area. This includes numerous regions of the United States, and a sizeable international audience from Canada, Europe, Asia, and Australia. Additionally, conference content is made available online by FASEB to facilitate dissemination and allow for those unable to attend the meeting to access the stellar scientific content. Expected Size and Composition of the Audience: We expect our audience to be very similar to that of the most recent in-person FASEB Hematologic Malignancies Scientific Research Conference in 2023, which had 155 attendees. Of these attendees, 45% were trainees (17% graduate students and 28% postdoctoral fellows). Eighty-five percent of attendees were from throughout the United States, and 15% were international, with Europe the second most highly represented geographic area. Of attendees with terminal degrees, 55% had a PhD, 11% had an MD, 22% had an MD/PhD, and 5% had another degree. Plans for Publicizing the Conference: We will make every effort to publicize the conference broadly. The conference will be publicized widely through social media platforms, hematology-focused organizations, and targeted outreach via email to investigators in the field and malignant hematology programs across the country and internationally. Evaluation Plan: It is important to continually iterate and improve this conference to adjust to changes in the field and participant needs. FASEB utilizes a robust survey platform to capture attendee feedback and suggestions for improvement. Additionally, each organizing team creates a document outlining changes they made to the conference that were successful and things they would like to have done differently. This gets passed to the next organizers to help them thoughtfully improve the conference. History of the Meeting and Description of the 2023 and 2021 FASEB Hematologic Malignancies Conferences: The first FASEB Scientific Research Conference on Hematologic Malignancies was organized in 1995 by Drs. Stanley Korsmeyer and Albert Deisseroth, and attracted more than 100 scientists from around the country and the world. The response was overwhelmingly positive and has remained so for the 15 conferences held since. The ability to forge long-lasting relationships is universally seen as one of the biggest strengths and assets of the FASEB Hematologic Malignancies conference. The 2023 meeting, conducted in an in-person format for the first time after COVID-19, drew an outstanding number of participants, both long-time and first-time attendees. Feedback was overwhelmingly positive, with the conference receiving an average rating of 4.3 stars. The only major issue noted in the feedback was that some participants would like more coverage of lymphoma and other lymphoid malignancies. Addressing this concern has been a major focus of our speaker planning for the 2025 meeting. There were also requests for more immunotherapy/tumor microenvironment speakers, and we have added a session on these topics to address this feedback. The 2021 meeting was held virtually due to COVID-19. While the meeting was overall very well received, particularly for showcasing innovative and cutting-edge research, the trainees also indicated that the limitations of the virtual format made it extremely difficult for them to engage in deep interactions with senior faculty and other trainees that they did not already know - key opportunities provided by past in-person meetings. This feedback from the 2021 virtual meeting highlights just how important the interactions facilitated by this conference are for scientific advancement and professional development for trainees. BUDGET A. Senior/Key Personel Julia Maxson PhD MPI 0.5 calendar months effort, 0% salary requested Sergei Doulatov PhD MPI 0.5 calendar months effort, 0% salary requested Participant/Trainee Support Costs Travel: $17,973 Other: Scientist Registration Support : $35,393 Number of participants/Trainees: 60 Total Participant Trainee Support Costs: $53,365 BUDGET JUSTIFICATION Purpose: The requested funds will help to realize a 50% discount for registration and housing costs for trainees (graduate students, postdoctoral fellows) who are invited to give presentations at the meeting. Funding for this meeting in prior years relied heavily on industry support. However, the current economic climate, which has put serious financial strain on all companies that have supported this meeting in prior years, threatens the financial viability of this meeting. Our goal is for NIH support to ensure that this outstanding scientific research conference can continue to serve as a thriving intellectual environment that will catalyze the continued intellectual develop- ment of our trainees into future leaders in the field. Prioritization strategy (as needed): In case we cannot offer a discount to all presenting trainees, we will prioritize supporting trainees from early-stage (pre-R01) independent investigators, as well as coming from labs lacking substantial funds to support meeting attendance of their trainees. Funding structure: Number of trainees to support: 60 trainees, based on the number of trainees who attended the most recent in-person FASEB hematological malignancies meeting in 2023 (which included 34 postdoctoral fellows and 21 students) plus anticipated growth of 10 additional trainees. Registration and housing costs per trainee: $1,642 ($1,089 registration + $553 for 4 nights of housing with 2 trainees per room). Total budget request: $1,642 per trainee x 65 trainees x 50% support requested = $53,365 ($1,089 x 65 x 0.5 = $35,393 registration ($553 x 65 x 0.5 = $17,973 housing) Plans for obtaining further financial support: As in past years, we will seek donations from private entities to fund other aspects of the meeting. This includes nonprofit foundations and pharma/biotech partners, including, but not limited to, the Leukemia & Lymphoma Society, Edward P. Evans Foundation, Novartis, Regeneron, eBiosci- ences, Stem Cell Technologies, etc. These additional funds will be dedicated to covering registration and travel costs for non-trainee presenters, as well as social events.